Olfactory neuroepithelial cell derived induced neurons for study of schizophrenia

PROJECT SUMMARY
The pathophysiology of common psychiatric illnesses such as schizophrenia is highly complex and
heterogeneous, in which multitudes of common and rare genetic variants and their epigenetic modifications
precipitate disease phenotypes. Over the last decade, in vitro modeling of neuropsychiatric illnesses has been
led by induced pluripotent stem cell (iPSC) based paradigms. These approaches have a special strength in
offering developmental readouts of genetic variations in neurons and organoids. However, the ability to
recapitulate complex phenotypes of the illness is hampered because epigenetic characteristics of donors are
erased by the stem generation process. The goal of this project is to develop and test directly-converted
induced neurons (called DCiNs henceforth) for their ability to manifest neurobiological characteristics of
schizophrenia. DCiNs are generated by bypassing the stem cell stage and are thus more likely to harbor
epigenetic characteristics of donors. The extent to which DCiNs cells can recapitulate neurobiological
phenotypes of donors, however, will vary depending on the epigenetic landscape of the source cells and the
methodology for conversion of source cells into neurons. Presently, skin fibroblasts (SFs) are commonly used
source cells for iN paradigms, although SFs, as non-neural cells, may not manifest epigenetic characteristics of
donors with neuropsychiatric illnesses. We propose using olfactory neuroepithelial (OE) cells, the only neural
cells readily obtainable from human subjects, as source cells for DCiNs paradigms. Importantly, the chromatin
accessibility of OEs is vastly different from SFs, particularly around neural genes. Among various iN
paradigms, we will test a transcriptional modulation-based approach, specifically using a) two transcription
factors, ASCL1 and NGN2 (N2A) and b) the transcriptional effector, microRNA (mir) 9/9*-124. We will first
characterize the source cells (OE vs. SF), in combination with transcriptional modulators (N2A vs. mir 9/9*-
124), for the ability to differentiate into neurons and recapitulate the epigenetic landscape of donors’ neural
cells (Aim 1). As a test of the utility of this paradigm for study of common neuropsychiatric illnesses, we will
apply this model to schizophrenia by examining DCiNs-OEs from patients with schizophrenia and controls to
delineate the extent to which they recapitulate disease-associated changes (Aim 2). The results of this project
will define the extent to which DCiNs -OEs recapitulate neurobiological phenotypes of donors’ and pave the path
for establishing the iN paradigms for other neuropsychiatric illnesses.

Public health relevance
PROJECT NARRATIVE Common neuropsychiatric illnesses such as schizophrenia are precipitated by complex interplay between genetic and epigenetic variations. Induced pluripotent cell-based in vitro research paradigms are a powerful approach to study neurodevelopmental consequences of rare genetic variations but fall short of recapitulating complex phenotypes incorporating epigenetic characteristics of patients. Here, we propose to develop a novel paradigm – the directly-converted, induced neurons derived from olfactory neuroepithelial cells - and test the extent to which this paradigm captures genetic and epigenetic signatures of individuals and apply this model to schizophrenia as a proof-of-concept study.